Mechanistic Investigation and Engineering of Histone Reader Proteins

Abstract.
The integral roles of histone post-translational modifications (PTMs), including lysine
methylation and acylation, in chromatin remodeling is well established, but new roles of histone
PTMs in disease are continually discovered. This rapidly evolving field necessitates the
development of new molecular approaches to probe the biological impacts of these PTMs.
Herein we focus on the reader proteins for lysine methylation and acylation as reader proteins
are responsible for sensing the PTM and triggering the biological outcome, and both r have
biomedical relevance. Our research will encompass development of new chemical biology tools
to investigate binding mechanisms, improve detection of PTMs, and to generate designer
nucleosomes to study the role of dual PTMs in biological pathways. This research is expected to
advance the ability to develop selective inhibitors and molecular probes for these two classes of
proteins. To develop new methods for creating new sensing methods and designer
nucleosomes, we will exploit the inherent selectivity of reader proteins to develop engineered
reader proteins (eReaders and eWriters) for sensing, labeling, and introduction of dual PTMs in
a site selective manner. This combined effort will advance the field by providing new insight and
new tools to study the biological pathways that depend on these PTMs and their role in disease.

Public health relevance
Project Narrative. Post-translational modifications of histone proteins regulates gene expression and dysregulation is associated with a wide range of diseases, making them an important medicinal target. However, many of the fundamental molecular mechanisms are still poorly understood and new chemical tools are needed to advance the field. This proposal develops new approaches to address these challenges and advance biomedical research in the field.